Rural and Urban Differences in Pubertal Development and Menstrual Characteristics in a Costa Rican Cohort

SUMMARY/ABSTRACT
The global trend toward earlier pubertal development has extensive public health implications, particularly for
low- and middle-income countries (LMICs) where age at menarche has been decreasing faster than in high-
income countries (HICs). Additionally, in several LMICs, the timing of menarche has been found to vary by
rural versus urban residence. As younger age at menarche is a risk factor for negative health outcomes like
reproductive cancers, obesity, and cardiovascular disease, understanding the timing and determinants of
pubertal development and menstrual characteristics may elucidate linkages between pubertal exposures and
related health disparities. Therefore, we propose to characterize patterns in the timing, tempo, and
determinants of pubertal development and menstrual characteristics in the Costa Rican study, Estudio de
Comparacion de Una y Dos Dosis de Vacunas Contra el Virus de Papiloma Humano (ESCUDDO). We
hypothesize that urban girls will experience earlier puberty, faster tempo, and shorter, regular menstrual cycles
compared to their rural counterparts. We will leverage data from the full ESCUDDO cohort and the
Immunogenicity Subcohort Group (ISG) which comprise of pubertal development and menstrual history from
Costa Rican girls ages 12-21 and ages 12-14 at baseline, respectively. We will first evaluate if the timing and
tempo of pubertal development and menstrual characteristics is earlier and faster in urban girls compared to
rural girls (Aim 1). Using data from the full cohort (n=24,782), we will ascertain differences in pubertal
development and menstrual characteristics across the rural-urban continuum in girls ages 12 to 21 using
parametric survival models for pubertal timing and mixed-effects models for pubertal tempo (Aim 1a). Using
longitudinal data from the ISG (n=1,408) we will update our estimates of pubertal timing and tempo (Aim 1b).
We will also determine if associations between determinants of earlier and faster pubertal development and
menstrual characteristics in predominantly HICs are also determinants in Costa Rica (Aim 2) by measuring the
effect of early pubertal development predictors including weight, BMI, prenatal and neonatal history, smoking,
and socioeconomic status on the timing and tempo of pubertal development and menstrual characteristics
using parametric survival models. The proposed study will be the largest comprehensive assessment of
pubertal development and menstrual characteristics in female adolescents to date and will help identify
populations at high risk of earlier, faster pubertal development and shorter, regular menstrual cycles. The
objectives outlined in this proposal will provide me with extensive experience in reproductive health research,
while contributing to the large knowledge gap of pubertal development globally. Furthermore, the combination
of rigorous training in advanced epidemiologic methods, experiential learning, and expert mentorship will
ensure my transition to a successful physician-scientist.

Public health relevance
NARRATIVE Earlier pubertal development, faster tempo, and shorter, regular menstrual cycles are linked to an increased risk of adverse health outcomes including reproductive cancers and metabolic syndrome. As pubertal trends are decreasing faster in low- and middle-income countries, determining the timing and tempo of pubertal development and menstrual characteristics are needed to inform normative data in these settings. Using both a large cross-sectional cohort and a longitudinal sub-cohort from Costa Rica, we will examine differences in the timing and tempo of pubertal development and menstrual characteristics across the rural-urban continuum in Costa Rica and identify predictors of earlier pubertal development in this understudied population.